Targeting Oxidative Stress to Prevent Vascular and Skeletal Muscle Dysfunction during Disuse

Disuse following injury, illness, or surgery is linked to functional deficiencies, hospital readmission, impaired
recovery, and increased mortality. Older Veterans are particularly vulnerable to disuse as functional (vascular
and skeletal muscle mitochondrial dysfunction) and structural (loss in muscle mass and strength) deficits are
present as a consequence of the aging process. The accelerated declines that occur during disuse further
deplete an already diminished physiological and functional reserve capacity. Current skeletal muscle-focused
strategies to mitigate atrophy and losses in strength are ineffective and the mechanism(s) contributing to
accelerated losses are unknown. Therefore, identifying the mechanism(s) and developing effective strategies to
minimize losses in vascular and skeletal muscle function, systems that are inextricably linked to mobility, disease
progression, and health, is critical to delay the onset of disability and preserve the health of older adults.
Supported by preliminary and previous data, it is our central hypothesis that oxidative stress triggers the
accelerated declines in vascular and skeletal muscle function during disuse. To mechanistically and
comprehensively identify the obligatory role of oxidative stress in disuse-induced dysfunction two novel and
fundamentally unique approaches to diminish oxidative stress are proposed including; 1) a mitochondrial
targeted antioxidant (MitoQ; Aim 1) and 2) the nuclear factor erythroid-2-like 2 (Nrf2) activator, PB125 (Aim 2).
A total of 72 healthy older men and women (> 65 yrs.) will be block randomized to 3 groups; CONTROL, MitoQ,
and PB125. Five days of bed rest, a model of disuse mimicking acute hospitalization, will be used to evoke
oxidative stress and losses in vascular and skeletal muscle function. In Specific Aim 1, participants will receive
MitoQ (consisting of mitoquinone) during 5 days of bed rest. It is expected that MitoQ will blunt the increase in
oxidative stress by limiting mitochondrial-derived reactive oxygen species (ROS) production leading to preserved
vascular and skeletal muscle function, thereby revealing a critical role of mitochondrial-derived ROS. In Specific
Aim 2, the novel Nrf2 activator, PB125, will be administered during 5 days of bed rest. It is expected that activation
of Nrf2 with PB125 will restore the age-related dysfunction of the Nrf2 signaling pathway resulting in the induction
of endogenous antioxidant enzymes that will, in turn, maintain redox balance induced by disuse. The primary
outcome measure for both aims is the assessment of vascular function as measured by passive leg movement
(PLM). Secondary outcome measures will assess the contributions of oxidative stress to the observed changes
in vascular and skeletal muscle function before and after bed rest and will include direct measurements of free
radicals, mitochondrial function and hydrogen peroxide production, markers of oxidative stress at the cellular,
tissue, and systemic levels, changes in muscle mass and strength, and changes in muscle protein and gene
expression that may be mechanistically linked to proteolysis and atrophy during disuse.

Public health relevance
There is an epidemic of disuse in older Veterans following injury and illness during which increased oxidative stress and accelerated losses in vascular and skeletal muscle function further diminish the already depleted physiological and functional reserve capacity of these older individuals leading to impaired recovery, disability, and increased mortality. The proposed project will examine the role of oxidative stress in disuse-induced vascular and skeletal muscle dysfunction by altering redox balance through two novel strategies, mitochondrial targeted antioxidants (MitoQ) and the Nuclear Factor Erythroid-2-like 2 (Nrf2) activator, PB125. Mechanistic insight will be gained by examining how these strategies impact oxidative stress, the key for triggering the accelerated losses in vascular and skeletal muscle function during disuse at the cellular, tissue, and systemic levels.